Prospective renal insufficiency cohort evaluation: PRICE

PROJECT SUMMARY
The CRIC Study was initiated in 2001 and enrolled its first participants in mid 2003. In the intervening
years the CRIC Study has consistently met recruitment goals in Phase 1 and Phase 3, and
maintained a high level of participant follow up during the study. We have published over 150
manuscripts and are entering the potential for a fourth phase (2018-2023) of funding during which we
hope to follow up the newly recruited participants from Phase 3 (2013-2017; n=1520) and those from
Phase 1 (2003-2008; n=3939) who are still active in the study.
We propose 12 Specific Aims that are common to each clinical center in this competing U01 renewal
application and provide background and methodology to incorporate and number of new
measurements into the CRIC Study. In particular, we are adding innovative measures that record 48
hours of heart rate variability, physical activity by accelerometry and breathing rate via the Zephyr
BioPatch, and 14 days of continuous ECG monitoring via the ZIO XT Patch. In addition, we plan
obtain measures of in-home monitoring for subclinical episodes of AKI using current technologies that
allow a fingerstick creatinine measurement and urine protein, albumin and creatinine measures to be
obtained at home and uploaded to the CRIC clinical center. In this application we will focus on our
Center's productivity in the CRIC study and in particular will showcase the remarkable opportunity
available in the understanding of heart failure, the single most common CV endpoint in the CRIC
study, through biometric monitoring using these new technologies, along with our site's experience
with a pilot study in this area.
In this application we will review important aspects of CKD and contributions of our clinical center to
the CRIC effort. This application includes a progress report from our site (101) as well as proposals
for data sharing and the recruitment of investigators at our Institution as well as outside our Institution
to participate in evaluating and publishing findings from this landmark study in the Nephrologic
Community that will further the mission of the NIDDK to promote kidney health and to design
interventions that mitigate the burden of CKD in the US adult populations with CKD.

Public health relevance
Project Narrative The CRIC Study began enrolling participants in 2003 and was designed to address the rate at which kidney failure progresses once it is established. Our findings to date have discovered several biomarkers (like fibroblast growth factor) that are important in kidney disease progression, and we have also noted marked variation in kidney failure progression. In the next phase our goal is to learn more about the role of acute changes in kidney function and to determine whether biometric devices (similar to Apple Watches and FitBits) will help us to understand cardiac disease in people with impaired kidney function.